PHYSICIAN INTERVENTION TO IMPROVE DIABETES CARE

This is a resubmission of a application reviewed in October 1999. This randomized trial will test the hypothesis that a) an influential physician feedback intervention; b) narrative process trace' feedback intervention, or c) the combined interventions (a+b) are no more effective than (d) usual care in improving the clinical care of adult patients with diabetes mellitus The unit of randomization and the unit of analysis will be primary care physicians who have more than 10 adult patients with diabetes mellitus. The 162 physicians eligible for this study provide care to about 6,804 adults with diagnosed diabetes at 24 primary care clinics. The narrative process trace intervention uses AMR-mounted clinical cases to assess physicians' diabetes care decisions, with results provided as feedback to physicians. The influential physician feedback intervention emphasizes individual education of physicians, which will be guided by the narrative process trace in the combined intervention. Usual care includes the use of a diabetes clinical guideline, use of a diabetes patient registry that provides key clinical data for each adult patient with diabetes, and access to clinic-based diabetes education nurses. The applicant has shown in previous controlled studies that the guideline, diabetes registry, and clinic-based education nurses have failed to significantly improve diabetes care on a population basis, thus justifying the additional strong intervention that now will be tested. Dependent variables include glycemic control and cardiovascular risk reduction of all 3360 patients cared for by the 80 study physicians. Secondary analysis will assess rates of screening for microvascular complications. Physicians will be randomized in blocks based on specialty, number of diabetes patients, and years of practice experience. Hierarchical data analysis will be used to accommodate the nested data and propensity scores will be used to correct for selection effects and missing data. Results of this experiment will advance the theoretical understanding of physician behavior change and quantify cost and impact of three specific intervention strategies to improve chronic disease care in the primary care setting. The study will have substantial impact on clinical practice and policy whether the results are positive or negative. If successful, the interventions will be easily disseminated to other primary care practice settings.